Combinational targeting histone and RNA modifications in prostate cancer

Abstract
Prostate cancer is one of the most common cancers among men, and although it can successfully be
treated in some men, others develop resistance to therapies and can relapse. Thus, it is prudent to discover
new therapeutic targets and develop therapeutic strategies that utilize already developed therapies to expedite
the development of new treatment options for prostate cancer patients. Prostate cancer can be caused at
genetic and epigenetic levels. Not only do epigenetic modifications include unwinding of genes (i.e., DNA) so
they can be expressed as RNA, but this epigenetic regulation can also edit RNA. One epigenetic modifier is
protein enzyme enhancer of zest homolog 2 (EZH2) that normally modifies the histone H3K27, thereby, tightly
winding DNA and silencing gene expression. Our previous work showed that EZH2 is upregulated in advanced
prostate carcinomas and metastatic prostate cancer, and prostate cancer patients who have higher expression
levels of EZH2 have shorter survival times than prostate cancer patients with low or no expression of EZH2.
Surprisingly, we recently discovered that dysregulation of EZH2 alters N6-methyladenosine (m6A), which is
totally different from its well-known canonical function as a histone lysine methyltransferase. mRNA
methylation can affect the stability of RNA and induce alternative splicing of mRNA, which will alter important
regulation of the RNA and protein translation fidelity. These aberrant effects on RNA by alterations in RNA
modifications are associated with cancer, in particular, prostate cancer. Therefore, investigating this novel
EZH2 non-canonical function in N6-methyladenosine will help us better understand the progression of
advanced prostate cancer. Although the development of EZH2 inhibitors has been an active area of
investigation and multiple biotech and pharmaceutical companies have been developing such drugs, EZH2
inhibitors alone have not been proven effective in most solid cancers. Thus, identifying new therapeutics
targets will lead to the development of new drugs that can be combined with already developed drugs, hence,
expediting the development of new treatment options for cancer. Our data show, for the first time, that EZH2
enhances global m6A modification levels via activating m6A reader YTHDF1, enhancing m6A writers
METTL14/WTAP protein synthesis, and inducing tumor suppressor mRNA degradation. Most advanced
prostate cancer cells have higher expression levels of EZH2 and m6A compared to those in benign prostate
epithelial cells and early-stage prostate cancer cells, suggesting the importance of EZH2 and m6A in prostate
cancer progression. In the proposed project, we will precisely identify how EZH2 regulates m6A via its non-
canonical role in prostate cancer. Understanding these mechanisms will lead to the future design of new
inhibitors of EZH2 and m6A writers/readers. Therefore, our work provides a novel rationale to target both
METTL3 and EZH2, and we predict that the inhibition of both m6A and EZH2 will achieve a better therapeutic
efficacy than inhibiting either m6A or EZH2 alone.

Public health relevance
PROJECT NARRATIVE EZH2 is a well-known histone lysine methyltransferase and an oncogene upregulated in many types of cancer, including prostate cancer. In this project, we will investigate the novel noncanonical role for EZH2 in mRNA m6A modification in prostate cancer. Successful completion of this project will provide novel mechanistic insights EZH2’s novel functions beyond its histone methyltransferase and transcription repressor activities.